Epigenetic Regulation of Embryonic and Hematopoietic Stem Cells

We previously showed that histone variant H2A.Z is critical for the self-renewal and differentiation by maintaining an open chromatin structure at key regulatory regions of transcription. It is also known that pluripotency of embryonic stem (ES) cells is controlled in part by chromatin-modifying factors that regulate histone H3 lysine 4 (H3K4) methylation. However, it remains unclear how H3K4 demethylation contributes to ES cell function. We showed that KDM5B, which demethylates lysine 4 of histone H3, co-localizes with H3K4me3 near promoters and enhancers of active genes in ES cells; its depletion leads to spreading of H3K4 methylation into gene bodies and enhancer shores, indicating that KDM5B functions to focus H3K4 methylation at promoters and enhancers. Spreading of H3K4 methylation to gene bodies and enhancer shores leads to differential gene expression during self-renewal and differentiation of Kdm5b depleted ES cells, and decreased enhancer activity, as measured by H3K27ac levels. KDM5B critically regulates H3K4 methylation at bivalent genes during differentiation in the absence of LIF or Oct4. We also show that KDM5B and LSD1, another H3K4 demethylase, co-regulate H3K4 methylation at active promoters but they retain distinct roles in demethylating gene body regions and bivalent genes. Our results provide global and functional insight into the role of KDM5B in regulating H3K4 methylation marks near promoters, gene bodies, and enhancers in ES cells and during differentiation.

We have recently addressed the regulation of histone variant H3.3 deposition in chromatin. We developed a Tet-inhibited expression system of epitope-tagged H3.3 and examined the relationship between H3.3-nucleosome turnover and ESC-specific transcription factors, chromatin modifiers and epigenetic marks. Our comprehensive analysis of H3.3 dissociation rates revealed distinct H3.3 dissociation dynamics at various functional chromatin domains. To understand how H3.3 dynamics is regulated, we have recently used proteomics approach to investigate H3.3-interacting proteins. We data indicate that a variety of chromatin-regulating proteins are associated with H3.3, which may regulate the deposition and turnover of H3.3 on chromatin.

Chromatin states are regulated by both active and repressive marks. However, the roles of repressive histone modifications such as trimethylated histone lysine 20 (H4K20me3) in pluripotency and development are largely unknown. We now show that the histone lysine methyltransferase SMYD5 (SET and MYND domain-containing protein 5) mediates H4K20me3 modification at LTR/LINE repetitive DNA sequences. Depletion of SMYD5 leads to compromised self-renewal, including dysregulated expression of OCT4 targets, and perturbed differentiation. SMYD5 bound regions are enriched with repetitive LINE and LTR elements. Knockdown of SMYD5 results in a global decrease of H4K20me3 levels, a redistribution of heterochromatin constituents including H3K9me3/2, G9a, and HP1, and de-repression of endogenous LTR/LINE elements. A combined depletion of SMYD5 and Suv420h1/h2 leads to even greater decreases of H4K20me3 levels globally. Moreover, a loss of SMYD5-dependent silencing of LTR/LINE repeats nearby genic regions leads to upregulated expression of lineage-specific genes, thus contributing to the decreased self-renewal and accelerated differentiation of SMYD5-depeleted ES cells. These findings implicate an important role for SMYD5 in regulating heterochromatin and repressing endogenous repetitive DNA elements.

In addition to histone modifications, the ATP-depedent chromatin remodeling SWI/SNF complexes play critical roles in controlling chromatin activities. Mutation of SMARCA4 (BRG1), the ATPase of BAF (mSWI/SNF) and PBAF complexes, contributes to a range of malignancies and neurologic disorders. Unfortunately, the effects of SMARCA4 missense mutations have remained uncertain. Here we show that SMARCA4 cancer missense mutations target conserved ATPase surfaces and disrupt the mechanochemical cycle of remodeling. We find that heterozygous expression of mutants alters the open chromatin landscape at thousands of sites across the genome. Loss of DNA accessibility does not directly overlap with Polycomb accumulation, but is enriched in 'A compartments' at active enhancers, which lose H3K27ac but not H3K4me1. Affected positions include hundreds of sites identified as superenhancers in many tissues. Dominant-negative mutation induces pro-oncogenic expression changes, including increased expression of Myc and its target genes. Together, our data suggest that disruption of enhancer accessibility represents a key source of altered function in disorders with SMARCA4 mutations in a wide variety of tissues.

More recently, we have applied single-cell MNase-seq to mouse ES cells. We found that about 30% of single cells are primed for differentiation even under the normal ES culture condition (Nature 2018). Furthermore, we characterized the chromatin states in hematopoietic stem cells and early T progenitor cells (Immunity, 2018; Nature Immunology 2019).

We have generated a large amount of data on the enhancer-promoter interaction using our TrAC-looping technique and deposited these datasets in the 4D Nucleome portal.

In collaboration with Paul Liu's and Paul Love's labs, we have investigated the critical roles of key transcription factor LDB1, Runx1 and CBXb in normal cellular differentiation and tumorigenesis.

My lab used single-cell epigenomics techniques to examine the differentiation potential of early innate lymphoid like cells and found that the transcription factors TCF1 and GATA3 play critical roles in establishing an epigenetic landscape for priming the cells toward innate lymphoid like cells. In collaboration with the laboratory of Dr. Jinfang Zhu, we have investigated the function of ILCs in the B cell residency in guts. In collaboration with laboratory of Dr. Tomihiko Tamura, we comprehensively determined higher-order chromatin structures by Hi-C in DC progenitors and cDC subpopulations.

In collaboration with Dr. Chuan Wu's lab, we investigated how the gut-liver axis regulates intestinal physiology. Through hepatectomy and transcriptomic and proteomic profiling, we identified pigment epithelium-derived factor (PEDF), a liver-derived soluble Wnt inhibitor, which restrains intestinal stem cell (ISC) hyperproliferation to maintain gut homeostasis by suppressing the Wnt/β-catenin signaling pathway. Furthermore, we found that microbial danger signals resulting from intestinal inflammation can be sensed by the liver, leading to the repression of PEDF production through peroxisome proliferator-activated receptor-α (PPARα). This repression liberates ISC proliferation to accelerate tissue repair in the gut.

The contribution of three-dimensional genome organization to physiological ageing is not well known. In collaboration with Dr. Ranjan Sen's lab, we found that large-scale chromatin reorganization distinguishes young and old bone marrow progenitor (pro-) B cells. These changes result in increased interactions at the compartment level and reduced interactions within topologically associated domains (TADs). The gene encoding Ebf1, a key B cell regulator, switches from compartment A to B with age. TADs that are most reduced with age contain genes important for B cell development, implicating three-dimensional chromatin reorganization as a major driver of pro-B cell phenotypes that impair B lymphopoiesis with age. In collaboration with Dr. Xin Chen's lab, we found

Using Drosophila as model system and in collaboration with Dr. Xin Chen's lab, we found that Drosophila germ stem cells (GSCs) display a distinct replication program compared to somatic lineages, that aligns with chromatin state differences, potentially linking chromatin modification, DNA replication and stem functions.